Dead Space and Inhaled Nitric Oxide in Pediatric Acute Respiratory Distress Syndrome

PROJECT SUMMARY
Mortality remains high (20%) for the 8,000 US children each year that develop pediatric acute respiratory
distress syndrome (ARDS). No pharmacologic therapies have been identified that decrease the mortality risk
from ARDS. This is likely due to underlying biologic heterogeneity among patients with ARDS that may result in
some benefiting from a therapy whereas others are harmed, limiting the ability to find effective therapies in
clinical trials of general cohorts. Inflammatory phenotypes have been described in ARDS that may help identify
underlying biologic differences contributing to heterogeneity in treatment effect. However, these phenotypes
cannot currently be identified in real-time. There is an urgent need for easily available markers to identify
clinically relevant heterogeneity in patients with ARDS. Markers of dead space may be promising for this
purpose. Dead space is area of the lung that receive ventilation without perfusion and reflects abnormal
pulmonary perfusion (microvascular dysfunction, low cardiac output) and alveolar overdistension. With routine
patient monitoring data (time-based capnography, blood gases), dead space can be estimated with the end
tidal alveolar dead space fraction (AVDSf). We have found in single-center studies that AVDSf is more strongly
associated with mortality risk than are markers of the severity of hypoxemia (oxygenation index [OI]) in early
pediatric ARDS. Dead space may also be an attractive marker for identifying heterogeneity of treatment effect
for therapies such as inhaled Nitric Oxide (iNO) that target pulmonary perfusion. iNO is a selective pulmonary
vasodilator, with additional anti-inflammatory and anticoagulation effects, that is commonly used off-label for
refractory hypoxemia in ARDS. But almost all clinical trials of iNO therapy have failed to demonstrate a benefit
when enrolling general cohorts of patients or selecting patients based on severity of hypoxemia. One small
pediatric trial found higher extracorporeal membrane oxygenation free survival suggesting the potential for
some subgroups to benefit from iNO therapy. Our preliminary data suggest that iNO therapy decreases the
AVDSf associated mortality risk and that a decline in AVDSf with iNO therapy is associated with improving
plasma markers of microvascular dysfunction. Our central hypotheses are that the routinely available AVDSf is
more strongly tied to mortality risk than OI and that AVDSf is an important marker of heterogeneity in the iNO
treatment effect in patients with ARDS. These hypotheses will be tested through the following Specific Aims:
1) validate AVDSf for risk stratification of mortality in pediatric ARDS 2) determine if there is heterogeneity in
treatment effect for iNO defined by AVDSf, and 3) detect the association between AVDSf and microvascular
dysfunction trajectory and whether iNO therapy modifies the association. Demonstrating that AVDSf
outperforms OI for mortality risk stratification in patients with ARDS and that AVDSf may identify the patients
most likely to benefit from iNO therapy, has the potential to be frameshifting for future clinical trials of ARDS
interventions, including those of iNO therapy.

Public health relevance
PROJECT NARRATIVE Children with acute respiratory distress syndrome (ARDS), a form of severe lung injury, have a high risk of death (20%) and there are no known beneficial medications to lower this risk. We will test whether measuring dead space, a marker of abnormal lung function, may improve our ability to identify which children are at highest risk of dying from ARDS and the children that may benefit from a medication to improve lung function (inhaled Nitric Oxide). The results of this research could have a major impact on designing clinical trials to identify therapies that may decrease the risk of mortality in ARDS.